The orexin system as a novel mediator of depression-like outcomes in female rats exposed to an endocrine disrupting compound during the peripubertal period

Project Summary
Age of puberty is one the most reliable predictors of later mental health outcomes in girls, with early menarche
greatly increasing the risk of depression in early adulthood. Environmental exposure to endocrine disrupting
compounds (EDCs) has been linked with early puberty onset in girls. Despite this, the neurobiological
consequences of EDC exposure, and how they might predispose to depression, remain poorly understood. In a
series of preliminary studies, we showed that peripubertal exposure to a model EDC, bisphenol-A (BPA),
accelerates puberty onset in female rats, and predisposes to behaviors in early adulthood that are reminiscent
of anhedonia, a core symptom of clinical depression. These changes were associated with a persistent
impairment in the functioning of the orexin neuropeptide system, the activity of which is normally important for
translating motivational states into reward behaviors. Specifically, BPA was associated with reduced reactivity
of orexin neurons to reward-predictive stimuli, as well as reduced orexin terminals in ventral tegmental area
(VTA), a key region through which orexins initiate reward-directed actions. Based on these data, we hypothesize
that: at doses that promote early puberty onset, BPA produces a persistent impairment in the functioning of the
orexin-VTA circuit. We predict that these changes are causally linked to the anhedonia-like phenotype observed
in early adulthood in BPA-exposed rats. Here, we propose three distinct, yet interrelated aims to begin testing
our hypothesis. In Aim 1, we will characterize the baseline activity (using electrophysiology) of VTA-projecting
orexin neurons in BPA-exposed rats and determine how this is related to the expression of anhedonia-like
behavior in early adulthood. In Aim 2, we will use fiber photometry recordings of a novel orexin sensor to measure
orexin signaling in VTA in response to reward-predictive stimuli. Finally, in Aim 3, we will use chemogenetics to
stimulate the orexin-VTA circuit to test its causal role in the expression of anhedonia-like behavior following BPA.
These studies will be the first to determine the effect of EDC exposure on orexin neurons and their circuits, and
will determine their mechanistic involvement in depression outcomes in a model of early puberty onset. The
proposed project is thus highly relevant to the goal of NIEHS to understand the impact of environmental chemical
exposures on psychiatric illness. Moreover, these studies are a critical first step for developing novel strategies
to improve mental health outcomes in young women.

Public health relevance
Project Narrative Early puberty in girls is one of the strongest predictors of depression in early adulthood. These studies will examine how exposure to an endocrine disrupting compound, which accelerates the onset of puberty, can alter a brain system important for mood. These studies will directly inform the development of novel strategies to improve mental health outcomes in young women.